Tolerance of Kidney and Islet Transplants via the Mixed Chimerism Approach

PROJECT SUMMARY (See instructions): Induction of specific immunologic tolerance is an ultimate goal of organ transplantation. Based on the conditioning regimen developed in our laboratory by decades-long research in nonhuman primates (NHP), we have now successfully achieved renal allograft tolerance in HLA mismatched human kidney transplant recipients via the mixed chimerism approach. However, limitations of this approach have been its inapplicability for deceased donor transplantation and the inability to induce tolerance of non-renal organs/cells. To extend this approach to deceased donor transplantation, we recently developed a novel strategy of

Public health relevance
RELEVANCE (See instructions): Successful induction of allograft tolerance has been achieved in HLA mismatched human kidney transplant recipients via mixed chimerism. This research proposal is directed to identify novel modalities to extend our mixed chimerism approach to a much wider population of human allograft recipients and to islet allograft tolerance. Our NHP model has been proven highly relevant to clinical organ transplantation and observations from these studies should be directly transferrable to clinical application.